Core B. ADMINISTRATIVE CORE

The Administrative Core serves an important role in integrating and facilitating the activities of the Program Project. Given that the Program is distributed in three sites and methodological expertise for three prongs of the Approach are centered respectively at these sites, exchange and materials and resources is critical for success of the Program. As such the Administrative Core will have the following objectives. 1) Establish and facilitate regular video teleconference meetings for all four research groups and for Pis 2) Coordinate the shipment and transfer of human and mouse tissues 3) Manage financial and track consortium agreements, and funds transfers. 4) Coordinate ad hoc review committee and review of the program.